Core D Functional Vision Module

Abstract
Functional Vision Core
The Functional Vision Core will provide the technologies required to interrogate visual function in experimental animals
to the investigators involved in this P30 Cole Eye Vision Research Core. The Functional Vision Core will provide state
of the art assessment of visual function in mice and zebrafish. This will include visual electrophysiological assays such
as the electroretinogram (ERG), pattern ERG, the visual evoked potential (VEP), and visual behavior assays such as the
optokinetic reflex (OKR), optomotor reflex (OMR) and threshold measurement. Collectively, these assays interrogate
visual function from light detection in the photoreceptors to signal integration and interpretation within the brain. This
Core will support NEI R01-funded investigators, help investigators obtain data for additional NEI R01 grant
submissions, foster collaborative interactions between R01-funded investigators, attract investigators from other
departments to research on the visual system and be a valuable departmental resource in attracting additional vision
scientists to our program as we expand our research faculty.